The Procurement of BioAnalyzers to Expedite and Enhance Services Provided by the National Natural Toxins Research Center

PROJECT SUMMARY:
Natural products have been a foundation of drug design, and snakes and other animal venoms have vast
potential. Snake venoms have provided molecular probes that have been used to decipher numerous
complex physiological and pathophysiological processes and have served as the starting point for
developing several important classes of drugs. The venom and anti-venom research fields depend on
access to reliable and reproducible venom-related resources developed by the National Natural Toxin
Research Center (NNTRC). The NNTRC requires equipment and instrumentation for storing crude snake
venoms, venom fractions, purified toxins, cloned products, snake and mice tissues, critical reagents (i.e.,
biochemical assays and reagents, antibodies, conjugated antibodies, and biological samples) used for
diverse translational research. The equipment and instrumentation being requested, two ultra-low
temperature freezers, a Bio-Plex 200 Multiplex Array System, a DxH 500 Hematology Analyzer, a Stago
STA Compact Coagulation Analyzer, and a DM1000 LED upright microscope, in the proposal are ideally
suited to support critical research for maintaining the biological samples for long-term storage, analyzing
biochemical protein markers in a multiplex format that provide more information from less sample volume
in less time than traditional immunoassay methods, determining the hematological variables and
coagulation parameters for the characteristic hematological abnormalities observed in snake
envenomation. The specific aims of the parent grant are to:
1. Operate the National Natural Toxins Research Center as a resource center that provides high-
quality venom and products that support biological and biomedical research to national and
international programs.
2. Develop and expand the collection of snakes, specialized services, and outreach programs to
support the growth of venom-related research in the U.S.
3. Conduct a state-of-the-art applied research program to support the development of new venom-
related research services.
Access to this equipment and instruments will enable the NNTRC to fulfill its specific aims and allow
researchers to make significant advances in the search for venom-derived therapeutics.
RELEVANCE:
Venom research is a diverse and multidisciplinary field that encompasses a range of scientific areas,
including biochemistry, pharmacology, ecology, and conservation biology. It could lead to the discovery
of new drugs, better antivenoms, and an improved understanding of venomous animals and their role in
ecosystems. The resources of the NNTRC have been applied to research in a wide range of these
disciplines, research that has been supported by multiple NIH I/C’s, the NSF, the Dept of Defense, and
national and international research agencies.

Public health relevance
PROJECT NARRATIVE Snake venoms have provided molecular probes that have been used to decipher numerous complex physiological and pathophysiological processes and have served as the starting point for developing several important classes of drugs. The instruments requested will perform several critical research studies that will expedite services, such as identifying biomarkers and coagulation factors due to envenomation and storing venom molecules and biological materials to maintain their integrity for rigor and reproducibility that can be used for future research and potential therapeutic use.